Administrative Core

Description of core unit: The Core will provide the following services: a) Serve as the administrative point of contact for all components, including consortia, of the Program Project Grant. b) Management of most of the speaker series, scheduling itineraries for quarterly speaker's series of visiting scientists. c) Coordination of internal and external review and interactions between projects and cores. d) Arrangement of most of the monthly meetings of project and core directors to discuss scientific progress. e) Arrangement of most of the meetings on a quarterly basis with the internal advisory board. f) Arrangement of most of the meetings on an annual basis with the external advisory board; assisting advisors with travel plans and reimbursements. g) Preparation of written summaries of meetings for distribution to project and core leaders, h) Providing support for the preparation and submission of manuscripts and reports. i) Providing first line accounting for all projects and cores. j) Assisting project leaders with intramural tasks such as managing radioactivity, animal and human use protocols, inspecflons, certifications and training, k) Providing human resource administration for program personnel. I) Submission of orders and recordkeeping of laboratory supplies and equipment